DNA sequence selectivity in conventional and aberrant V(D)J recombination

Project Summary
The vast repertoires of antigen receptors (AgRs) in the adaptive immune system are dependent on V(D)J
recombination. In this somatic rearrangement process, component gene segments are assembled to generate
functional AgR genes during distinct stages of B and T cell development. Each gene segment is flanked by a
recombination signal sequence (RSS) which is recognized and cleaved by the V(D)J recombinase, containing
RAG1 and RAG2, in the first enzymatic steps of V(D)J recombination. As the RSSs are only semi-conserved,
the V(D)J recombinase must be capable of cleaving at a wide range of variant RSSs to generate diverse AgR
repertoires. However, there are millions of cryptic RSS-like sites (cRSS) that are located throughout the genome.
Erroneous RAG-mediated cleavage at cRSS sites can cause oncogenic chromosomal rearrangements.
Therefore, RAG1/2 must be promiscuous to facilitate recombination of poorly conserved RSSs at AgR loci, but
it must also be precise to avoid off-target cRSSs. Long standing questions remain as to the contribution of DNA
sequence selectivity, along with the effects of the chromatin environment, on the balance between conventional
versus aberrant V(D)J recombination events. To address the contribution of DNA sequence selectivity to V(D)J
recombination, we developed a high-throughput recombination method to analyze RSS selectivity, in which the
relative efficiency of V(D)J recombination on RSS substrate libraries are obtained by analysis of next generation
sequencing results. Using this method, we will empirically characterize RSS motifs that enhance RAG1/2 activity
to shape a diverse antigen receptor repertoire, as well as identify suboptimal RSS motifs that favor
nonconventional V(D)J recombination reactions. Our preliminary studies have yielded highly informative results,
which have shown preferred sequence motifs and sequence interdependencies between different regions of the
RSS that have significant consequences on the level of V(D)J recombination activity. Furthermore, specific RSS
motifs appear to preferentially favor nonconventional V(D)J recombination reactions. Building on our preliminary
results, we hypothesize that the specific relationships within RSSs 1) influence their relative utilization by the
RAG proteins, 2) are modulated by specific chromatin environments, and 3) govern their fate in conventional
versus aberrant V(D)J recombination reactions. Overall, we predict that findings from this project will significantly
improve our current understanding of RAG selectivity of RSSs and cRSSs in normal and aberrant V(D)J
recombination reactions, respectively.

Public health relevance
PROJECT NARRATIVE In developing B and T lymphocytes, functional antigen receptor genes are assembled from component gene segments by V(D)J recombination through a DNA cleavage and joining mechanism. In this project, we will decipher patterns in DNA sequences that govern the efficacy of V(D)J recombination using a recently developed cellular recombination assay that is coupled with a high throughput sequencing approach. Findings from this study will be important for elucidating how the antigen receptor repertoire in the adaptive immune system is formed, as well as the basis for aberrant recombination reactions that can lead to oncogenic chromosomal rearrangements.